Data Science Core

Project Summary – Data Science Core
The field of data science has exploded in growth within the biomedical sciences in recent years, driven in part
by artificial intelligence approaches using trained neural networks to analyze large data sets. Existing high-
performance computing resources will be consolidated and expanded at the University of Arkansas to establish
a Data Science Core in the proposed Arkansas Integrative Metabolic Research Center (AIMRC). The Data
Science Core will be a unique core created to meet the research needs of the AIMRC and is an essential
component of the research projects proposed by the COBRE project leaders. A team of four data scientists will
be assembled that have broad expertise to provide data science support for AIMRC. The Data Science Core will
coordinate closely with the AIMRC Bioenergetics and Imaging and Spectroscopy Cores to provide artificial
intelligence-based approaches to elucidate relationships between large imaging, bioenergetics, genomic, and
proteomic data sets, which can ultimately be used to predict and understand metabolic phenotypes and their
role in disease. This coordinated core structure will allow data analytics to be integrated into a cross-disciplinary
framework capable of supporting the entire range of technologies and expertise needed for an effective metabolic
systems research. Close interaction between the Data Science Core and COBRE Center project leaders will
also lead to new innovations in research that will benefit future COBRE investigators as well as the broader
campus research community. Opportunities and training in data science will be provided by the core directors to
AIMRC members, the campus and researchers in Arkansas.